CSHL Computational Genomics Course

The Cold Spring Harbor Laboratory proposes to continue a course entitled “Computational Genomics”, to
be held in the Fall of 2020 – 2024. The Computational Genomics course provides experimental
biologists with backgrounds in molecular biology, genetics, and biochemistry with the theoretical
background and practical experience necessary to use and evaluate computational approaches to
genome annotation and analysis, including protein sequence database searching, multiple sequence
alignment, identification of promoters and other genetic regulatory elements, and the integration of
sequence information into broader models of biological function. The course also provides computer
scientists and mathematicians with an introduction to the algorithms, computational methods, and
biological problems that are addressed in biological sequence analysis and computational biology. For
post-doctoral fellows, and junior and senior investigators who are interested in changing their research
direction towards computational biology, the course provides an introduction to computational biology
methods and a survey of future directions. Over an eight day period, the students receive a strong
grounding in the both the biological and computer science foundations for genome analysis and practical
computer laboratory experience on challenging problems. The course is taught by internationally
recognized leaders in the field, who provide hands-on demonstrations of the programs and biological
databases that they have developed. At the end of the course, students can not only use effectively
currently available tools in biological sequence analysis, they can also evaluate critically new
computational approaches by considering alternative methods and interpretations, and appreciate the
strengths and limitations of computational methods for answering broad biological questions.

Public health relevance
NARRATIVE The Computational Genomics, an 8 day course, is designed to meet the continuing need for training in computational biology, statistics, and computer science for molecular biologists and geneticists with backgrounds in experimental biology. In addition, the course presents problems in biological sequence analysis and biological databases to biologists and computer scientists. The course covers research topics and state-of-the-art techniques that are essential to the interpretation of genome sequence and large-scale functional analysis data, from a perspective that balances the theoretical foundations of the approaches and their experimental and analytical limitations.